Neurostimulation Enhanced Cognitive Restructuring for Transdiagnostic Emotional Dysregulation: A Component Analysis

Emotional dysregulation constitutes a serious public health problem and novel approaches are needed to
effectively address it transdiagnostically. Despite rapid advancements in affective and cognitive neuroscience,
there have been few attempts to translate basic findings into novel interventions. In addition, the relevance of
different nodes in the emotion regulation network to psychopathology and to successful reduction of emotional
arousal is not yet fully understood. Noninvasive neurostimulation, such as repetitive transcranial magnetic
stimulation (rTMS), is a powerful tool with which dysfunction can be alleviated temporarily, by modulating
neural activation. Therefore, the objective of the current study is to examine immediate neural and behavioral
changes following neuromodulation enhanced emotion regulation training for transdiagnostic adults who report
difficulties calming down when upset. The central hypothesis is that neurostimulation enhances the
acquisition of emotion regulation skills and leads to remediated neural function in the emotion regulation
network. Our long-term goal is to develop novel interventions that harness neuroscientific findings to advance
behavioral treatments.
The primary aim of this project is to evaluate the unique neural and behavioral effects of a one-session training
combining cognitive restructuring (CR), an emotion regulation skill, with excitatory rTMS over the dorsolateral
prefrontal cortex (dlPFC). The secondary aim is to identify key changes in the emotion regulation neural
network following the combined intervention versus each of the components alone. The third aim is to explore
personalized biomarkers for response to emotion regulation training. To achieve these aims, 240 rTMS naïve,
community adults who meet criteria for affective or stress DSM-5 disorders (excluding if co-occurring anorexia,
alcohol and substance use, bipolar I, or psychotic disorders) and who self-report high emotional dysregulation
and low use of CR will participate in brain imaging while undergoing an emotional regulation task. Participants
will be randomly assigned to CR training (groups 1 & 2) or to psychoeducation about emotions (group 3; aimed
to control for nonspecific factors). Participants will be reminded of recent stressors and will undergo real
(groups 1 & 3) or sham (group 2) high frequency rTMS, targeted using fMRI results. Participants who learned
CR will practice this skill during rTMS in a one-time session, and physiological arousal will be monitored
throughout the emotion induction and regulation practice. Following this training, participants will undergo
another functional scan and an exit interview to assess for immediate neural and behavioral changes. Bio-
behavioral measures of emotion regulation will be assessed at a one week and a one month follow up visit. If
successful, our line of research will provide key mechanistic information to develop a novel transdiagnostic
treatment for affective and stress disorders.

Public health relevance
Difficulties in managing emotions contribute to the development and maintenance of affective and stress disorders, and, therefore, constitute a significant public health problem in need of novel, rapid interventions. To address this transdiagnostic need, we plan to characterize neural changes that result from practice of emotion regulation skills enhanced with neurostimulation targeted towards the emotion regulation network. The findings of this study will be used to refine a combined psychotherapy and brain stimulation intervention.